Maternal health interventions in California hospitals: Understanding approaches & implementation to advance equity

PROJECT SUMMARY/ABSTRACT
This is a Mentored Research Scientist Career Development Award (K01) award for Dr. Sarah B. Garrett, PhD,
a medical sociologist and Assistant Professor at the University of California, San Francisco (UCSF). Dr. Garrett
is establishing herself as an investigator of healthcare facilities’ efforts to advance maternal health equity. This
K01 will provide Dr. Garrett with the support necessary to become an expert in this field and to lay the foundation
for an independent research career focused on reducing racial/ethnic inequities in maternal health.
Dr. Garrett will be supported by an outstanding mentorship and advisory team with expertise in the
proposed training areas: maternal healthcare, implementation science, and health equity-promoting
interventions. Co-Primary Mentors are: Dr. Dan Dohan (UCSF), expert in health policy, institution-focused
qualitative research, and medical culture; and Dr. Melissa Simon, MD, MPH (Northwestern), an obstetrician and
NIMHD-funded clinician-investigator who has deep expertise in the application of implementation science to the
design, evaluation, and scaling of impactful maternal health equity interventions. Co-Mentors will be Dr. Brittany
Chambers, PhD, MPH (UC Davis), a preeminent scholar of antiracist birth equity interventions and community-
based methods; and Dr. Melissa Rosenstein, MD, MAS (UCSF), a national leader in conducting and researching
maternal health quality improvement. Scientific Advisors are: Dr. Christine Dehlendorf, MD, MAS (UCSF), an
NIMHD R01-funded expert in reproductive health equity interventions and their implementation in large
institutions; Dr. Hector Rodriguez, PhD (UC Berkeley), an expert in health system effects on disparities in patient
care quality and outcomes; and Dr. Patience Afulani, PhD, MD, MPH, an expert in measuring and improving
patient experience of maternity care. Under the team’s close guidance, Dr. Garrett will gain proposed skills and
knowledge via coursework, mentored tutorials, and practical experience.
Hospitals are well-positioned to advance birth equity, but there is inadequate evidence to guide them. Dr.
Garrett proposes to use stakeholder guidance, implementation science, and antiracist frameworks to investigate
California hospitals' health equity-promoting intervention efforts. Focusing on interventions intended to decrease
racial/ethnic inequities in maternal care quality and outcomes, she will: Aim 1) Characterize how a diverse set
of California hospitals are working to reduce maternal health inequities; Aim 2) Identify drivers of equity-focused
practice change in facilities participating in a collaborative program; and Aim 3) Generate actionable community-
led guidance for hospitals’ birth equity intervention work. This implementation-focused K01 will provide
evidence- and community-based guidance for facilities’ selection and implementation of maternal health equity
interventions. It will form the basis of an R01 to examine how health equity interventions affect patient outcomes
(clinical, experiential) in diverse hospital settings across the country.

Public health relevance
NARRATIVE It is a national priority to combat maternal health inequities, which disproportionately affect individuals from Black, Indigenous, and other minoritized communities. Hospitals are well- positioned to advance birth equity, but there is inadequate evidence to guide their intervention efforts. The proposed research will use in-depth interdisciplinary methods and guidance from affected communities to generate new insights about how hospitals are working to advance maternal health equity, about the factors helping or hindering their efforts, and about ways to align this work with their communities’ priorities.